Enhancing Venetoclax Activity in Chemoresistant Acute Myeloid Leukemia

Project Summary
Dr. Jacqueline S. Garcia is an Instructor in Medicine at Harvard Medical School/Dana Farber Cancer Institute
(DFCI) with research interests in the biology of relapsed acute myeloid leukemia (AML) and therapeutics
targeting chemoresistance. The applicant, Dr. Jacqueline Garcia, presents a 5-year career development program
designed to support an academic, clinical/translational investigator. The proposed research project will take
advantage of the clinical and scientific expertise and resources available at the DFCI, which has a long-tradition
of training clinical investigators. This includes a mentorship committee led by Dr. Richard Stone, a highly qualified
and internationally recognized AML clinical trialist. This research will promote training in areas critical to Dr.
Garcia’s career goals: clinical research methods, principles of human research, and translational research tools
as it pertains to conducting patient-oriented investigations. Her long-term goal is to be an independent leukemia
investigator and develop novel scientifically-sound clinical trials for patients with relapsed AML. This proposal
seeks to gain biological understanding of the role of functional assays in leveraging the activity of venetoclax-
based therapies in chemoresistant AML settings to prevent and treat relapse. Key mediators of the anti-apoptotic
pathway determine the cellular response to chemotherapy. Biological tools such as the BH3 profiling assay,
developed by her co-mentor Dr. Anthony Letai, offers the unique opportunity to evaluate a myeloblast’s readiness
to undergo apoptosis (based on cytochrome c release in the presence of BH3 peptides) and its anti-apoptotic
dependencies. Dr. Letai has also developed a drug-specific BH3 profiling assay called dynamic BH3 profiling
(DBP) which measures apoptotic priming following short-term ex vivo drug exposure. Preliminary data shows
that DBP predicts in vivo response to individual or a combination drugs after short-term ex vivo drug exposure.
Venetoclax, a selective BCL-2 inhibitor and BH3 mimetic, is an active drug in acute myeloid leukemia but requires
a drug partner(s) to boost its potency. Her central hypothesis is that BH3 profiling tools will identify effective
personalized drug combinations that will enhance the activity of venetoclax in patients with chemoresistant
myeloblasts. The work outlined in this proposal will use BH3 profiling assays to examine the role of venetoclax
immediately prior to transplant to reduce relapse and at time of relapse. She proposes to: (Aim 1) determine the
impact of adding venetoclax to conditioning chemotherapy on the risk of relapse after transplantation for patients
with poor risk MDS and AML, (Aim 2) characterize the mitochondrial apoptotic priming state in myeloblasts at
diagnosis and upon progression on combination venetoclax and hypomethylating agents to understand acquired
resistance, and (Aim 3) determine the impact of using DBP to guide optimal venetoclax-based drug combinations
to improve response in relapsed AML. If successful, this project will provide evidence of direct clinical translation
from the laboratory and provide a new approach for identifying personalized AML therapies.

Public health relevance
Project Narrative Most patients diagnosed with acute myeloid leukemia (AML), a lethal blood and bone marrow cancer, must face disease recurrence (or relapse), which emerges due to development of chemoresistance. This proposal seeks to leverage drugs that target the anti-apoptotic pathway using functional biological tools to prevent and treat relapse. This work will provide a deeper understanding of pathways that are essential to the development of chemoresistance and reveal novel therapeutic opportunities.